Beyond Nano, Challenges and Opportunities In Drug Delivery

Abstract The Beyond Nano, Challenges and Opportunities in Drug Delivery symposium is one of the Soft Materials and Biomaterials symposium clusters of the 2021 MRS Spring Meeting & Exhibit, to be held on April 18-23, 2021, Seattle, Washington. The theme of the Beyond Nano, Challenges and Opportunities in Drug Delivery symposium is the reflection on nano-/cancer-centric drug delivery research that has driven the field in past two decades and the exploration of new opportunities in drug delivery technologies with a specific focus on a materials science perspective. The MRS meeting is a unique forum for scientists at all levels, from eminent experts to young scientists, in multiple disciplines related to materials science, including chemistry, engineering, and other applied sciences. The MRS Soft Materials and Biomaterials symposia historically attracted the audience in the field of drug delivery and tissue engineering with topics related to cutting-edge biomedical products. The objective of this symposium is to provide a forum for investigators at all levels in allied disciplines including material scientists, chemists, engineers, and pharmaceutical scientists and help them to share the lessons learned to date, discuss the challenges and innovation in materials science in overcoming current bottlenecks in drug delivery, and cultivate new opportunities that can benefit from the advances in nanomedicine. The organizing committee consists of four experts in drug delivery field across the globe: Prof. Yoon Yeo of Purdue University (USA) chairs the symposium, and Profs. Patrick Stayton of University of Washington (USA), Youqing Shen of Zhejiang University (China), and Yosi Shamay (Israel) serve as co-chairs to plan, organize, and moderate activities of the symposium. The committee has identified six thrust areas of fundamental and current interest in drug delivery field: (i) Machine learning for drug delivery design; (ii) Nanomedicine; (iii) Bioinspired materials for drug delivery; (iv) Local drug delivery; (v) Drug delivery for global health; and (vi) Biomaterials and drug delivery for immunotherapy; and confirmed the participation of twenty-three leaders and rising stars as invited speakers. We plan to achieve three Specific Aims through the Beyond Nano, Challenges and Opportunities in Drug Delivery symposium: Aim 1. Critically reflect on the advances and challenges in core fields of drug delivery; Aim 2. Discuss the latest developments in materials science on emerging fields of drug delivery; Aim 3. Provide a stimulating and dynamic convention to engage and inspire early-career scientists. The NIH symposium support is being sought to support registration fees and travel expenses for invited speakers and young investigators, prioritizing (i) early-career invited speakers, and (ii) graduate students, post-doctoral trainees, and young investigators, including members of underrepresented minority groups.

Public health relevance
Project Narrative The Beyond Nano, Challenges and Opportunities in Drug Delivery symposium at the 2021 Materials Research Society (MRS) Spring Meeting in Seattle will invite scientists at all levels from diverse disciplines related to drug delivery to present and exchange new data and cutting-edge discoveries. Given the focus on multidisciplinary interactions of scientists in drug delivery field, this symposium meets the NIH's mission to advance prevention, detection, diagnosis, and treatment of disease for betterment of human health on the basis of interdisciplinary interactions integrating engineering and physical sciences with biology and medicine.